Defining the Role of Alternative Polyadenylation in Macrophage Differentiation and Function

Project Summary:
Macrophages are key effector cells of the immune system, with critical functions in killing of microbes,
production of inflammatory regulators, and tissue repair. However, an excessive macrophage response
contributes to the pathology of cancer as well as inflammatory and degenerative diseases. In addition,
unchecked proliferation of macrophage precursors in lieu of differentiation leads to acute myeloid leukemia. To
better address how to modulate macrophage function to help abate diseases that involve changes in
macrophage biology, we must understand the critical molecular pathways that govern macrophage
differentiation and regulate their activity.
We propose that one of these pathways will involve mRNA polyadenylation, an essential maturation step in
which mRNA precursor is trimmed at its 3' end and a poly(A) tail (pA) added. Changing the position of the pA
site through a process called alternative polyadenylation (APA) plays an important, increasingly appreciated
role in regulation of gene expression. Shortening of the 3' untranslated region can remove regulatory
sequences that control RNA stability, translation, and subcellular localization, whereas coding region
shortening can dramatically alter protein function. While global changes in APA have been observed in tumor
progression and other types of cellular differentiation, the contribution of APA to macrophage differentiation
has not been studied.
We hypothesize that a global shift in APA is required for macrophage differentiation and that this shift is
driven by changing levels of APA regulators. Our objective is to determine how APA contributes to
macrophage differentiation, with the long-range goal of defining how this might be manipulated in therapeutic
settings to promote differentiation and modulate macrophage function. Our specific aims will 1) determine the
global pattern of APA during macrophage differentiation, the functional classes of genes impacted by APA,
and sequence features that might characterize these sites, 2) define drivers of macrophage APA and the
consequence that altering their expression has on differentiation as well as well-characterized macrophage
functions such as cytokine production, migration, and phagocytosis, and 3) determine the molecular
mechanisms that alter the levels of the proteins that regulate APA. Because macrophage are a first line of
defense for many diseases and dysregulation of their differentiation leads to leukemias, our proposed studies
should ultimately inform new therapeutic tools to modulate macrophage production. They will also broadly
advance our understanding of general and tissue-specific APA paradigms. s

Public health relevance
Project Narrative: This proposal is designed to understand how a post-transcriptional mechanism that determines mRNA fate by altering mRNA length contributes to timely and efficient differentiation of macrophages. These cells of the innate immune system are critical for combating infections and for tissue repair, but blocks to their differentiation can lead to leukemias. Thus, the proposed research is relevant to the part of NIH's mission that pertains to advancing fundamental knowledge of important cell processes that could lead to novel treatment strategies for human disease.